Investigating the Causal Role of Particulate Matter Components on Lewy Body Dementia: Integrating Epidemiologic and Mechanistic Evidence

Project Summary
As the United States population ages, the number of individuals affected by Lewy body dementia (LBD),
characterized by hallmark α-synuclein (αS) pathology, is expected to rise. LBD, which profoundly impairs
cognition, behavior, and mobility, currently affects 1.4 million individuals and their families in the United States.
It is also the costliest dementia subtype to Medicare, with costs nearly double those of Alzheimer's disease.
The growing health burden of LBD highlights the urgent need to identify and modify environmental factors that
may contribute to its development. Increasing scientific evidence suggests that air pollution, particularly fine
particulate matter (PM2.5), plays a significant role in the development and progression of αS-related dementia.
Mechanistically, αS-related dementia may begin when foreign agents, such as PM2.5, enter the body via the
nose or gut, triggering αS propagation in the brain and ultimately leading to dementia.
Despite this, critical gaps remain in understanding the interaction between PM2.5 and LBD. Specifically, it is
unknown which specific components of PM2.5 contribute to LBD via αS pathology. To address these gaps, we
propose utilizing large-scale epidemiological data, advanced statistical methods, and mechanistic animal
studies to identify which PM2.5 components associated with LBD diagnoses in human populations and
investigate how they promote αS aggregation and prion-like spreading in vivo. We have assembled a
multidisciplinary team of experts, including an atmospheric scientist, biostatistician, environmental
epidemiologist, neurologist, and neuropathologist. The biostatistical and epidemiological experts will have
access to 100% of the Medicare chronic condition data—including inpatient, outpatient, and prescriber claims
data—from approximately 27 million Medicare enrollees in the United States from 2017 to 2022, where many
LBD diagnoses are recorded. In parallel, the atmospheric chemistry and neuropathology experts will have
access to laboratory resources for aerosol generation, atmospheric particle characterization, and a whole-body
exposure (WBE) inhalation system to mimic ambient PM2.5 exposure to mice.
The complementary expertise will enable us to examine the role of PM2.5 and its specific components in
contributing to LBD. (1) We will evaluate the long-term effects of total PM2.5 exposure on LBD risk and
establish an exposure-response relationship among Medicare enrollees. (2) We will quantify the effects of
individual PM2.5 components and their mixtures on LBD risk using novel causal modeling approaches. (3) We
will conduct in vivo studies using a WBE system in wildtype and αS-deficient mice to explore the causal
mechanisms through which specific PM2.5 components, such as black carbon and nickel, induce αS pathology
and neurodegeneration. By identifying the specific PM2.5 components most responsible for LBD risk and
elucidating the biological pathways involved, our research will provide critical evidence to inform targeted air
pollution policies and therapeutic strategies aimed at reducing the health burden of LBD in older populations.

Public health relevance
Project Narrative As the United States population ages, the number of individuals affected by Lewy body dementia (LBD), characterized by hallmark α-synuclein pathology, is expected to rise, highlighting the urgent need to identify modifiable environmental factors, such as air pollution, that may contribute to the disease. We propose to utilize large-scale epidemiological data, advanced statistical methods, and mechanistic animal studies to determine which components of fine particulate matter (PM2.5) contribute to LBD and investigate how they promote α-synuclein aggregation and prion-like spreading. By identifying the specific PM2.5 components driving α-synuclein pathology and neurodegeneration, we aim to provide critical evidence for targeted air pollution policies and therapeutic strategies to reduce the health burden of LBD related to air pollution.